Translational and Computational Analysis of Dialysis Fistula Maturation Failure-2

ABSTRACT
Many of the insights into pathologic versus adaptive arterial remodeling have been achieved through a detailed
understanding of the linkage between endothelial/smooth muscle cell biology and the local hemodynamic forces
that modulate their response pattern. In the normal arterial circulation, where moderate shear stress, laminar
flow patterns predominate, the response patterns following intervention have been well delineated and are the
cornerstone for successful therapies. In contrast, the complex, high-energy, chaotic flow environment, which
characterizes the AVF, breaks these established hemodynamic-biologic relationships. Aim 1 will explore the
mechanosensing mechanisms that are instrumental in the interpretation of these forces and examine their
downstream effect on shifting the smooth muscle cell (SMC) to a pro-proliferative, synthetic phenotype. In a
more global sense, understanding the unique response patterns within the AVF flow environment are
instrumental to moving the field forward and providing the needed insights to design the next generation of
biologic therapies to improve AVF outcomes. Aims 2 and 3 will perform a systems-based analysis of the critical
genomic changes that dictate successful versus failed AVF remodeling and utilize a multi-scale model to identify
those key elements within the network that should move forward for further translational investigation.
Supported by our preliminary data, we propose that the intima and media have unique response patterns
following AVF creation. Using laser capture microdissection, high-throughput genomics and advanced network
analysis, the current project will produce a multi-scale, computational model links changes in gene expression
network to alterations in SMC and matrix biology and ultimately alterations in the remodeling response of the
AVF architecture. Using this model, a systematic analysis of the biologic response to genomic perturbations can
be explored, effectively performing a progression of in silico experiments to identify those key opportunities in
the genomic response where the needed balance between expansive remodeling and modulated hyperplastic
growth can be achieved. Within this context, the following Aims are proposed:
SPECIFIC AIM 1: Explore the biomechanical linkage between AVF creation and SMC phenotype and evaluate
the impact of these changes on AVF adaptation and successful (or failed) physiological maturation.
SPECIFIC AIM 2: Delineate the changes in genome-wide expression patterns associated with AVF creation and
identify unique genomic signatures that are associated with successful AVF remodeling.
SPECIFIC AIM 3: Create and explore a dynamic gene regulatory network, which in combination with a multiscale
computational model of vascular adaptation, identifies the subset of genes that have the most significant
influence on augmenting outward remodeling and reducing intimal hyperplasia following AVF placement.

Public health relevance
NARRATIVE Although a functional arteriovenous fistula (AVF) is considered the preferred type of vascular access for maintenance hemodialysis, approximately 50% of new AVFs fail to mature. Among the major impediments to designing the next generation of biologic therapies to improve AVF outcomes is the limited understanding of the biology that regulates the remodeling response patterns in early stages following AVF creation. Fundamental to this project is a systems-based analysis of the critical genomic and metabolomic changes that dictate successful versus failed AVF remodeling.